DIFFUSION SPECTRUM MRI OF STRUCTURAL CHANGES IN WHITE MATTER IN DEMENTIA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The overall goal of this project has been to develop robust methods for analysis of brain connectivity using diffusion spectrum imaging, investigate possible modes of 3D spatial correlations within the fiber architecture of the brain.